FDA Food NARMS

Project Summary – Missouri State Public Health Laboratory (MSPHL)
The Missouri Department of Health and Senior Services (DHSS), Missouri State Public
Health Laboratory (MSPHL) proposes to support the National Antimicrobial Resistance
Monitoring System (NARMS) Retail Meat Surveillance Program by continuing its current
sampling of retail meats and testing for Salmonella and Campylobacter, Enterococcus,
Aeromonas, Vibrio and other bacteria of interest. Sampling and testing will be
performed as directed in the NARMS Retail Meat Surveillance Laboratory Protocol,
including Whole Genome Sequencing and uploading of the data. Specifically, enhanced
sampling consisting of retail meat samples will be collected in the mid-Missouri area and
tested monthly. The MSPHL will ship all isolates to the FDA Center for Veterinary
Medicine (CVM) monthly and perform monthly sample and testing data exchange with
NARMS using the electronic log sheets provided by NARMS. Outcomes include the
testing of required number of retail meat samples annually, which will lead to increased
numbers of isolates submitted, improved data quality, sample diversity and timeliness of
isolate and data submissions. In addition, the sharing and review of testing and
antimicrobial data will be used by epidemiology programs to detect food borne disease
outbreaks and coordinate investigations; educate DHSS administrators, local public
health officials and the general public on current and emerging health hazards; support
food safety program awareness of antimicrobial resistance among the public; analyze
for trends to inform DHSS management and assist with policy development; and data
will be used by the laboratory to assess accuracy of testing results and quality
assurance practices.
Page 1 of 1

Public health relevance
The Missouri Department of Health and Senior Services (DHSS), Missouri State Public Health Laboratory (MSPHL) proposes to support the National Antimicrobial Resistance Monitoring System (NARMS) Retail Meat Surveillance Program by continuing its current sampling of retail meats and testing for Salmonella and Campylobacter, Enterococcus, Aeromonas, Vibrio and other bacteria of interest. This project will enhance the collection of data on the occurrence of antibiotic resistant bacteria in the nation’s retail meat supply, and further the aims of NARMS through data sharing with state and federal epidemiologists. In addition, the sharing and review of testing and antimicrobial data will be used by epidemiology programs to detect food borne disease outbreaks and coordinate investigations. Page 1 of 1